Task C04: Development of a Human Intestinal Enteroid Monolayer Culture System for Human Norovirus

This contract provides for the development and standardization of nontraditional animal models of infectious diseases and may include candidate product efficacy testing, including GLP studies to support licensure.